Soluble guanylate cyclase in diabetic retinopathy

Diabetic retinopathy is a major cause of blindness worldwide. Current treatments are available only
advanced stages of DR. There is a great need for identifying regulators and therapeutic targets.
Research advances have expanded our understanding of DR. These include the role of protective
factors in DR, the pathophysiologic effect of oxidative stress, and the multi-faceted nature of DR as a
disease of the neurovascular unit that involves multiple cell types. This includes neuroretinal
dysfunction and neurodegeneration that are early abnormities in DR which can contribute to disease
progression. Soluble guanylate cyclase (sGC) is a key enzyme for nitric oxide (NO) signaling.
Oxidative stress is known to inhibit sGC in systemic settings, including diabetes, via oxidation of the
sGC prosthetic heme, leading to its inactivation and eventual loss. This is notable since oxidative
stress is known to be an important driver of DR progression. Drugs promoting sGC are in use for
some systemic conditions and are continuing to be actively developed, highlighting the translational
potential of targeting this molecule. Our lab has found that an sGC activator drug exerts
neuroprotective effects in rodent models of diabetic retinopathy. We have further found evidence for
a functional role for sGC in the retina. In this proposal, we seek to expand our studies of sGC with
respect to its role in diabetic retinopathy. We will use a combination of in vitro and in vivo approaches
to explore the potential inactivation of sGC in retina by diabetes and its stressors. In addition, we will
explore the cell-specific roles of sGC in the retina using conditional knockout mice. The proposal
could advance sGC as an important regulator and target in DR and also increase understanding of
the interplay of retinal cell types in this condition, shedding further light into DR as a disease of the
neurovascular unit.

Public health relevance
Diabetic retinopathy is a major cause of blindness worldwide, and there is a great need to identify new molecular targets. Current anti-VEGF drugs address only advanced stages of disease and are only partially effective. This research will investigate soluble guanylate cyclase as a novel regulator of DR and shed light into its various potential effects, providing a new molecular target for therapy.